Non-cyp51A-mutation Mediated Triazole Resistance in Aspergillus fumigatus

A critical barrier to overcoming triazole resistance in Aspergillus fumigatus is the significant lack of
understanding of its genetic and molecular basis. We have shown that the known mechanisms of resistance do
not fully explain resistance observed among most clinical isolates. Our long-term goal is to improve antifungal
therapy and ensure the sustained clinical utility of the triazole class for treatment of infections caused by
Aspergillus species. Our central hypothesis is that non-cyp51A-mutation mediated mechanisms are essential
to triazole resistance in clinical isolates of A. fumigatus and involve complex genetic changes altering 1) sterol
biosynthesis and its transcriptional activation, 2) triazole transport and its transcriptional activation, and 3) as yet
unknown mechanisms. Our current objective is to address critical knowledge gaps by identifying the genetic
and molecular determinants of non-cyp51A-mutation mediated resistance. Our preliminary data suggest that
while mutations in cyp51A among triazole resistant clinical isolates are common, their overall contribution to
resistance is minimal. We have observed mutations, unique to resistant isolates in our collection, in genes
encoding sterol sensing proteins, regulators of sterol biosynthesis, and sterol biosynthesis enzymes. We have
also observed clinical isolates that overexpress not only cyp51A, but most genes of the ergosterol biosynthesis
pathway, suggesting its constitutive activation. We have observed several potential transporters that are up-
regulated among triazole resistant isolates in our collection, suggesting a role for triazole efflux and resistance
by these transporters. We have also shown that clinical isolates of A. fumigatus take up triazole antifungals via
facilitated diffusion and we believe that altered triazole import may represent an important mechanism of
resistance. To accomplish our objective we will undertake experiments that will lead to an understanding of what
genetic and molecular determinants influence triazole susceptibility through altered sterol biosynthesis or its
transcriptional activation (Aim 1) and triazole transport and its regulation (Aim 2). In Aim 3, we will also utilize an
unbiased whole genome comparisons, coupled with in vitro evolution experiments, to identify completely novel
mechanisms of resistance in clinical isolates. Our approach is innovative as we will use the latest genetic and
genomic techniques to study and discover novel non-cyp51A-mutation mediated mechanisms of triazole
resistance that are operative in a U.S.-based collection of triazole resistant clinical isolates. The proposed
research is significant as it represents a comprehensive analysis of the molecular and genetic basis of non-
cyp51A-mutation mediated triazole resistance in A. fumigatus and will provide novel insights into ways in which
triazole activity can be improved against this important human pathogen.

Public health relevance
PUBLIC HEALTH RELEVANCE: Aspergillosis is associated with high morbidity and mortality among immunocompromised patient populations. The recent emergence of antifungal resistance in Aspergillus is threatening our already limited therapeutic armamentarium for this disease and represents a major impediment to effective treatment. It is of vital importance to understand how resistance develops in Aspergillus, so that this knowledge can be translated into therapies that prolongs the lives of affected individuals.